PHYSICAL ACTIVITY--EFFECTS ON ENERGY METABOLISM IN AGING MEN AND WOMEN

The purpose of this study is to correct information on the effects of fluctuation in physical activity (i.e. active and inactive lifestyles) on resting energy expenditure and sympathetic nervous system activity in older and younger men and women.